Laboratory Flexible Funding Model for Food Defense and Human Food Testing - Colorado

LFFM Overall Summary
The CDPHE laboratory performs comprehensive testing of food products for microbiological and
chemical contaminants. The laboratory has a long history of successful participation in FDA
proficiency testing to demonstrate capacity for testing, including high consequence pathogens.
The laboratory routinely participates in regulatory investigations of food contamination.

Public health relevance
LFFM Overall Narrative The CDPHE laboratory is eager to participate in the FDA Laboratory Flexible Funding Model program in order to support microbiological and chemical testing of food products in Colorado. Participation in the program will allow continued surveillance for contamination of food products as well as expand needed WGS testing to these commodity types and demonstrate capability to respond to contamination with high consequence pathogens.